Librational Mode Coupling Theory of Allosteric Signal Transmission

Project Summary: Libratioal Mode Coupling Theory of Allosteric Signal Transmission
The allosteric effect in proteins is the modulation of functional behavior due to interaction
with an effector ligand or a mutation at a region distal to the active site. Allostery is a critical
feature of all metabolic control processes, the mechanisms of action of biomolecular machines
and motors, gene expression, and many other biological phenomena. Notably, the time frame of
an allosteric effect is ~10-3 – 1 seconds, but the length scale can be quite long (100 Angstroms
in the DNA repair protein, MutS). Recent reviews report diverse examples fn the state of
experiment and theory of the allosteric effect in diverse examples, but all concur that the
molecular mechanism of allosteric signal propagation in large proteins remains an unsettled
research question. Recently (2020) some experiments that can track the time evolution of an
allosteric signal have been reported, but remain to be fully interpreted. A number of hypotheses
about how allostery works at the molecular level have been proposed, including pathways of
cooperative amino acid residues, flexibility/rigidity models, energy landscape - ensemble theory,
and complex networks, all of which have some plausibility. However, each has been applied to
positive instances in only one or just a few proteins in a class, and typically do not include
statistical controls nor explain ligand binding or mutations which have potential but do not elicit
an allosteric effect (negative instances). A particular challenge with large proteins has been
accounting for the propagation of allosteric signals over long range without attenuation. A
promising hypothesis pursued here postulates that long-range signal transmission occurs as an
allosteric effector-induced perturbation transmitted via coupling with the delocalized breathing
motions of a protein, i.e. “librational mode coupling” (LMC). The proposed research involves
elucidating the extent to which LMC contributes to allosteric signaling using “state-of-the-art" all-
atom molecular dynamics (MD) computer simulations together with our LMC analysis,
considering both motional and energy options for obtaining modes. The specific objective of
this proposal is the development and testing of a quantitative metric diagnostic of allosteric
signal propagation via LMC as applied to MD simulations on selected, well-characterized
allosteric proteins. The results of the proposed LMC-MD studies may either support or refute the
role of breathing motions, with either outcome contributing valuable new knowledge. Success of
this project will result in new fundamental knowledge about allosteric control processes that will
be ultimately useful in allosteric drug design.

Public health relevance
Project Narrative: Librational Mode Coupling Theory of Allosteric Signal Transmission The mechanism of allosteric signal transmission over long distance in large protein and assemblies is an unsolved problem and active area of research in biophysical science. A plausible but sparsely studied idea is that the allosteric signal is transmitted by coupling of the perturbation of an allosteric effector to low-frequency delocalized, librational modes of motion. The proposed research uses molecular dynamics computer simulations, principal component analysis, and Markov State Models on diverse allosteric proteins to elucidate the viability of this idea.